Diabetes Mellitus and Disorders of Metabolism

PROJECT SUMMARY/ABSTRACT
This proposal seeks continued support for the Yale research-training program in Diabetes Mellitus and Disorders
of Metabolism. This program seves as the core of support for postdoctoral research training in diabetes and
metabolic diseases at the Yale School of Medicine. A major goal of the program is to provide physicians and
scientists with the research expertise required to pursue clinical, translational and basic research in an academic
setting. Physician trainees entering the program will have M.D. or M.D., Ph.D. degress and at least 2-3 years of
clinical training in internal medicine or pediatrics. Ph.D. scientist are also recruited into the program since we
believe an integrated training experience bringing together adult endocrinologists, pediatric endocrinologists and
endocrine scientists is necessary to prepare our trainees to participate in modern multidisciplinary research
groups. Trainees are selected based on their aptitude and commitment to a research career. The duration of
the training period is three years to ensure an in-depth training experience leading to the ability to pursue an
independent research career. The cornerstone of the curriculum is the participation of each trainee in a specific
research project under the supervision of a designated preceptor and guided by a progress committee composed
of 2-3 other members of the training faculty. Potential projects run the gamut from clinical to basic research in 3
primary areas of emphasis: 1) type 1 diabetes, 2) type 2 diabetes, and 3) bone and mineral metabolism. Within
these areas, trainees have the opportunity to work with mentors in several basic science departments as well as
those in Pediatrics and Medicine. Close interactions among preceptors and trainees within each programmatic
area are enhanced by the interdepartmental Diabetes Research Center adminstered within the Endocrine
Section, which further enriches the training experience. Multiple educational opportunities including two degree-
granting (MS, PhD) programs are available to trainees through the CTSA-funded Yale Center for Clinical
Investigation. Instruction is also provided through organized lectures, research seminars and journal clubs. The
application requests a continued allotment of 6 stipends per year to support the combined Adult and Pediatric
Training Program instituted in the last funding cycle. Our request is based on our long history of maintaining an
outstanding track record of training successful investigators who remain in academic research careers, our
ongoing ability to attract outstanding applicants, the high level of research productivity of our training faculty, the
expansive palette of research opportunities provided by our diverse faculty and the continued shortage of
physician-scientists and scientists in both medicine and pediatrics that are dedicated to research careers in
diabetes and metabolic diseases.

Public health relevance
PROJECT NARRATIVE Obesity, diabetes and osteoporosis are increaingly prevalent metabolic diseases that are reponsible for a great burden of suffering and death as well as large healthcare expenditures in the US and throughout the world. Academic endocrine researchers are needed in order to better understand these diseases and to translate research findings into new and improved therapies. Our training program in Diabetes and Disorders of Metabolism is dedicated to providing young physicians and scientists with the research training necessary to tackle these important public health problems.